Epigenetic and metabolic bottlenecks of tumorigenesis

Recurrent metastasis is the leading cause of breast cancer mortality. Dormancy is a critical, but poorly
understood, step in the tumorigenic process where breast cancer cells can remain in a non-proliferative state at
secondary sites for long periods of time after successful treatment of the primary tumor. Reactivation of dormant
breast cancer cells (dDCCs) enables recurrent metastatic disease often resistant to standard of care therapies,
and as such dDCCs represent a major clinical obstacle in breast cancer patient care. Chromatin remodeling
provides the foundation for the cellular reprogramming necessary to drive cell fate transitions. However, little is
known about the nature of this remodeling in the context of dormancy. Our published work demonstrated that as
breast cancers acquire the ability to disseminate, canonical histone H3 incorporation into chromatin is
suppressed and replaced by a rare histone H3 variant, H3.3, incorporated by its cognate histone chaperone,
HIRA. This switch in histone composition is sufficient and necessary to enable dissemination and consequently
promote breast cancer metastasis. Our subsequent studies revealed that HIRA is not only important for acquiring
metastatic ability within the primary tumor but also for controlling the transition between dormant and proliferative
states, thereby serving as a major regulator for the fate of DCCs. Thus, here we propose that H3.3 deposition
driven by the HIRA complex regulates breast DCCs’ fate through the metastatic cascade, determining whether
the cells enter and remain dormant or proliferate and form overt metastases. This hypothesis will be tested
through three specific aims: Aim 1 will focus on establishing H3.3 deposition into chromatin as the effector of
HIRA in regulating the proliferation to dormancy switch in breast DCCs and the specific mechanism by which
HIRA-mediated H3.3 deposition exerts its effects while aim 2 will focus on precisely defining the inflection points
in the metastatic cascade regulated by HIRA-mediated H3.3 deposition and their metabolic/redox requirements.
Aim 3 on the other hand will focus on defining the role of the HIRA-H3.3 chromatin remodeling axis in mediating
the interaction between the lung environment and the fate of dormant cancer cells. Successful completion of
these studies will unveil for the first time a major regulator of the epigenetic remodeling that drives the
establishment of and exit from dormancy. Consequently, the proposed studies will put forward HIRA as an
important therapeutic target to prevent reawakening and consequently the active recurrence of metastatic breast
cancer. Moreover, our studies will enable the unbiased discovery of redox and metabolic pathways that support
vitality of the different cell states during the metastatic cascade enabling future studies aimed at evaluating said
pathways as much needed liabilities with therapeutic relevance to eradicate dormant cells and effectively prevent
recurrent metastatic breast cancer.

Public health relevance
While we have significantly advanced the therapeutic options for breast cancer over the past decades, recurrent disease, often in a highly aggressive metastatic form, occurs years or even decades after remission and represents a significant hurdle in our ability to effectively cure breast cancer patients. Recurrent disease is thought to be powered by a process known as dormancy, which is when disseminated cancer cells from primary tumors temporarily inactivate and later re-awaken in a metastatic form; despite known to occur for over 60 years, our understanding of the molecular circuits that regulate this process is very limited, which has hindered the development of efficacious therapeutics that target disease relapse and prevent patient mortality. Here, we aim to gain a deep understanding of the cell-intrinsic pathways that drive dormancy and allow breast cancer cells to retain vitality in this state as well as how these cell-intrinsic pathways are fine-tuned by the environment at secondary organs with the overarching goal of unveiling new therapeutic targets for inactive breast cancer cells and thereby lead to the development of targeted therapies that can effectively prevent recurrent metastatic disease in breast cancer patients.